Tulane National Primate Research Center AIDS SPF Breeding Colony Maintenance

PROJECT SUMMARY/ABSTRACT
The Tulane National Primate Research Center (TNPRC) is one of seven National Primate Research Centers
(NPRCs) sponsored by the National Institutes of Health. The Center is dedicated to providing the infrastructure
and support for basic and applied research efforts to advance scientific knowledge and improve human and
animal health and wellbeing. The TNPRC has one of the largest specific pathogen free (SPF) rhesus monkey
breeding colonies in the United States. Over the past 5 years, this breeding colony produced between 595-957
infants annually and provided close to 2,000 animals for biomedical research programs, including those focused
on AIDS.
Award U42OD024282 funds the establishment and maintenance of the TNPRC SPF breeding colony to support
AIDS research. The TNPRC AIDS research program is the largest at the Center, currently accounting for 61%
of all grant funding and 67% of animals assigned to research at the TNPRC on an annual basis. The SPF
breeding colony also provides rhesus macaques to affiliate investigators outside of the TNPRC for AIDS
research. In 2022, 361 SPF rhesus macaques were requested for AIDS research by TNPRC and affiliate
investigators. Of those, 312 have been allocated with the remainder awaiting assignment. Essentially all SPF
rhesus monkeys utilized in AIDS research programs at the TNPRC are derived from the U42-supported TNPRC
breeding colony. The TNPRC SPF program supports a variety of AIDS-related studies, including vaccine
development, pre-exposure prophylaxis, microbicides, AIDS/TB coinfection, transmission pathogenesis, and
cure research. Currently, there is high national demand for SPF macaques which requires the continued
availability and enhancement of this resource.
The proposed supplement to the U42 will be used to renovate an existing housing enclosure unit that has been
decommissioned. The renovation will bring the facility to state-of-the-art status and incorporate additional
measures to protect animals during inclement weather events. The housing enclosure renovation is within the
scope of the of the parent award and does not overlap with any U42-funded projects. The benefits realized from
this improvement will expand the TNPRC SPF rhesus macaque research infrastructure to assure these colonies
are sustainable and able to provide high-quality research models well into the future.

Public health relevance
PROJECT NARRATIVE Specific pathogen free (SPF) rhesus macaques represent a critical, high-demand resource for AIDS research. This supplement to a Tulane National Primate Research Center (TNPRC) U42 award provides funding to renovate an existing, unused outdoor housing enclosure for SPF rhesus macaques. SPF rhesus macaques will support a variety of AIDS-related studies, including vaccine development, pre-exposure prophylaxis, microbicides, AIDS/TB coinfection, transmission pathogenesis, and cure research. The benefits realized from this improvement will assure these SPF colonies are sustainable and able to provide high-quality AIDS research models well into the future.